IL-1R1, MMP-9, and EAE

PROJECT SUMMARY
Multiple sclerosis (MS) is a significant neurological disease affecting millions of people in the US.
This disease is believed to be driven by autoimmune activities against the myelin sheath in the
central nervous system. MS is modeled by the experimental autoimmune encephalomyelitis
(EAE), which mimics many aspects of MS. Interleukin-1 (IL-1) signaling has been shown to be
essential for the pathogenesis of EAE, but which cell-type specific IL-1 receptor mediated
processes are required for EAE are unclear. In addition, matrix metalloproteinase 9 (MMP-9) is
known to play an important role in mediating the breakdown of the blood brain barrier during EAE.
Our preliminary results show endothelial IL-1 receptor type 1 (eIL-1R1) and T cell IL-1 receptor
type 1 (TcIL-1R1) may both be required to mediate different aspects of the EAE pathogenesis,
and IL-1R1 and MMP-9 may amplify each other’s function during EAE. This application is
designed to: 1) Demonstrate eIL-1R1 and TcIL-1R1 combine to mediate EAE induction; 2) Identify
the roles of MMP-9 in eIL-1R1 and TcIL-1R1 mediated autoimmune processes; and 3) Determine
whether IL-1R1 and MMP-9 specific inhibitors synergistically block EAE induction and progression.

Public health relevance
PROJECT NARRATIVE This study investigates the role of endothelial and T cell interleukin-1 receptor type 1 (IL-1R1) in mediating the pathogenesis of experimental autoimmune encephalomyelitis (EAE) (an animal model of multiple sclerosis) and also how IL-1 signaling and matrix metalloproteinase 9 (MMP- 9) activity is linked. We will then determine whether inhibition of IL-1 and MMP-9 can synergistically block EAE induction and progression. The results could help develop a new strategy for the treatment of multiple sclerosis.